The assembly and function of cellular contractile systems

1) Background and key gaps in our understanding. Cellular force generation drives processes vital for
eukaryotic life, including cell division, cell migration, and muscle contraction. Thus, the basic principles underlying
cellular force generation are central to both developmental biology and the progression of force-dependent
diseases like cancer. Cells generate force by assembling cellular contractile systems. Contractile systems
emerge from the collective action of individual components within a larger molecular assembly. Our first
investigation into cellular contractile systems focused on the class of molecular motors responsible for generating
contractile forces, myosin II. The force-generating form of myosin II is a filament. A given myosin II filament can
contain multiple, distinct myosin II paralogs (i.e., hetero-filaments), wherein each individual myosin II paralog has
unique biophysical properties. Previously, the specific function(s) of myosin II-containing hetero-filaments within
contractile systems was unknown. Our work during the ESI MIRA funding period has revealed multiple roles for
hetero-filaments in the context of cell division and muscle contraction. Future work should address how hetero-
filaments are regulated, influence mechanical output, and cooperate with other contractile system components.
2) Description of recent progress by the PI. In non-muscle cells, we reported that hetero-filaments serve
multiple functions. Myosin IIA filaments seed the formation of myosin IIB filaments in both interphase and
mitosis/cytokinesis (Fenix et al. 2016, Taneja et al., 2020). The presence of myosin IIA in hetero-filaments drives
cortex tension (Taneja et al. 2020) and is regulated by both myosin IIA turnover and by phosphorylation of the
myosin IIA regulatory light chain (Taneja and Burnette 2019, Taneja et al. 2021). Meanwhile, the presence of
myosin IIB in hetero-filaments stabilizes the cell cortex during mitosis/cytokinesis and regulates cytokinetic
fidelity through multiple mechanisms (Taneja et al. 2020). Within cardiac muscle cells, we reported that
NMIIA/NMIIB hetero-filaments seed filaments of the muscle-specific myosin paralog, β myosin II, and are found
exclusively in the sarcomere precursors known as muscle stress fibers. We also experimentally demonstrated
that muscle stress fibers directly give rise to sarcomeres (Fenix et al. 2018, Taneja, Neininger et al. 2020). 3)
Overview of future research program. Here, we propose to build upon our findings from the ESI MIRA by
taking a multi-faceted approach aimed at three areas: A) We will continue elucidating how specific molecular
components of myosin II filaments, as well as those of other contractile system proteins like α-actinin and formins,
regulate cellular force production. B) We will determine the roles, and specific differences in function, of the non-
muscle and muscle paralogs of myosin II, α-actinin, and potentially other sarcomeric proteins during both
sarcomere formation and mitosis/cytokinesis (we have found that some muscle paralogs re-localize from the
sarcomere to the cortex during cell division). C) Finally, we will use zebrafish embryos to test the hypotheses
that come out of our in vitro experiments in vivo.

Public health relevance
Determining the mechanisms by which myosin II-based contractile systems assemble has promise to provide a mechanistic understanding of force-dependent pathological processes leading to diseases, such as cancer and cardiovascular disease. Identification of therapeutic targets to modify the forces driving disease could have health benefits for the public at large. The research proposed here aims to develop a molecularly detailed and predictive model of how contractile systems generate force to drive cell division, cell movement, and muscle contraction, with the ultimate goal of distinguishing mechanisms used by normal vs. aberrant cells.